Macrolide resistance transfer in Streptococcus pyogenes

PROJECT SUMMARY
Group A Streptococcus (GAS) is a strict human pathogen that primarily infects the epithelia at the throat or
skin, leading to ~750 million infections per year. High rates of morbidity and mortality result from invasive GAS
(iGAS) disease. Despite its importance as a global pathogen, there is no vaccine available for GAS. In the
C.D.C.'s Antibiotic Resistance Threats Report of 2019, erythromycin-resistant GAS are listed as a “concerning
threat” and the % of invasive GAS (iGAS) isolates resistant to erythromycin has recently tripled. Macrolides are
commonly prescribed for patients with β-lactam allergies, and lincosamides are highly effective against iGAS
disease because exotoxin production is halted. The problem of antibiotic-resistance in GAS is further
compounded by 2019-2020 reports on the emergence of stable β-lactam resistance due to altered penicillin-
binding proteins; the potential for lateral spread of resistance genes to other GAS strains is very high.
The proposed study seeks a deeper understanding of the biological causes and clinical consequences of the
acquisition by GAS of mobile genetic elements (MGEs) harboring macrolide-resistance genes (R-genes). Aim
1 seeks to define the genetic architecture of the (near) complete repertoire of MGEs that harbor macrolide-
resistance genes in GAS. Aim 2 uses experimental models of horizontal transfer of R-gene-MGEs between
GAS strains, to optimize microenvironmental conditions and to generate isogenic pairs of parental-recipient
and new recombinant strains. Aim 3 evaluates the effect of MGE acquisition on host cell phenotypes that are
independent of drug-resistance; several cargo genes are predicted to alter global gene expression and/or
contribute to virulence. Transcriptomes and fitness will be compared for the isogenic pairs. A mouse model for
iGAS disease will test the hypothesis that MGE acquisition leads to an increase in the intrinsic virulence of the
new recombinant. If correct, data may explain the epidemiological findings on the high association of
macrolide-resistance with iGAS disease and thereby, provide a platform for future studies that probe molecular
mechanisms.
Tools to be developed from the proposed work include a consolidated structural organization for the macrolide-
resistance MGEs, to be posted on the interactive user-friendly www.pubmlst.org website (Aim 1), and improved
experimental protocols for horizontal gene transfer by filter-mating (Aim 2). In addition to testing the hypothesis
that MGEs impart phenotypic changes in an antibiotic-free environment, transcriptome analysis (Aim 3) is
exploratory and may provide a window into critical molecular mechanisms.

Public health relevance
PROJECT NARRATIVE Group A streptococci cause a diverse array of >700 million infections each year throughout the world; GAS disease can be deadly. Fundamental knowledge of the biology of this bacterium, such as how it acquires resistance to antibiotics, and why some strains emerge and spread among humans, will facilitate a better understanding of the GAS disease processes and aid in the development of vaccines.